Systematic dissection of viral genetic interactions and mutations with COEXPRES-Seq

Project Summary/Abstract
In order to survive, a virus must manipulate the host cell environment, favoring its own replication while
combating antiviral pathways. Viruses only encode a handful of genes, so most viral genes play multiple
essential roles, and interact in order to form larger complexes with additional functions. Even subtle mutations
can add a further layer of complexity, enabling different phenotypes to arise from closely related viral species.
However, cataloging the functions of viral genes and their interactions remains unaccomplished for most
viruses. Consequently, we cannot yet decipher the grammar by which viral genotype influences pathology and
other complex phenotypes. I will perform comparative genomics to dissect the molecular basis of 4 strains of
LCMV, which encode few genetic differences and yet cause distinct impacts on the liver and immune system.
First, I will study the direct effect of infection on hepatocytes and dendritic cells (DCs) ex vivo. In
addition to inoculating cells with each LCMV strain, I will glean mechanistic insights by pinpointing which
gene(s) activate each cellular pathway. I propose to optimize COEXPRES-Seq (COmbinatorial EXpression
Perturbation to Reveal Emergent Systems), a pooled genetic expression screen with a single-cell genomics
readout. I will use this platform to quantify the contribution of each of the 4 LCMV genes, and their 15
combinations, in altering cell state (Aim 1). This study would be the first of its kind, as no study has
systematically studied all combinations of a virus' genes. I expect to find emergent properties—pathways which
are dysregulated only when, for example, both the WE Z and NP genes are expressed in hepatocytes.
Next, I will study in vivo pathology. To explore the basis of WE-mediated hepatitis, I will challenge mice
with WE or Arm strains, and perturb key pathways in the hepatocyte cell environment such as NF-κB and
STAT1 (Aim 2). To better understand severe systemic disease, I will dually engraft mice with mouse or human
liver and immune system and challenge these with both strains. By measuring hepatocyte and infiltrating
immune cell states, I will identify differences between the two strains. Finally, I will investigate the molecular
basis for DC infection and persistence of Arm/Cl13 and WE/Doc (Aim 3). I will develop molecular recorders of
infection and inflammation, and associate patterns of these events with long-term changes in DC state.
Together, this proposal is a first step in learning the rules that govern the viral genotype-phenotype relationship.
My K99 training will be supervised by a distinguished mentoring committee: Drs. Alex Ploss (mentor),
Britt Adamson (co-mentor), Yuri Pritykin (multiomics), and Juan C. de la Torre (LCMV), a vibrant intellectual
environment. These individuals are experts in their fields, and will guide me as I learn new topics, such as
state-of-the-art mouse models, genetic interactions, and trajectory analysis. In addition, I plan to further my
growth through participation in conferences in systems biology and virology, courses of lab management, and
writing workshops. The training in my K99 will launch me into an independent academic research position.

Public health relevance
Project Narrative Viruses employ a small number of genes that must work together to replicate and take over a host cell, but currently, scientists have no method to predict how a mutation in these genes might affect a virus' properties—whether it can infect a human or not, or whether it causes mild or severe disease. Focusing on LCMV, a small RNA virus that only encode 4 genes, I propose to study each gene individually, all 15 combinations of these genes, and how different strains of LCMV cause liver disease and persistent infection. By understanding how viral genes interact and how these strains cause distinct disease outcomes, I hope to predict how new mutations might alter a virus, and lay the groundwork for identifying new antiviral targets that disrupt these interactions and prevent disease.